Synaptosomal MicroRNAs, Synaptic Damage and Cognitive Decline in Alzheimer's Disease

Project summary: The purpose of our study is to determine the role of synaptosomal microRNAs (miRNAs) in
Alzheimer’s disease (AD) progression and pathogenesis. Synapses are the most important compartments of
neuron that deliver signals to adjacent neuron and maintain healthy synaptic functions of the brain. Recently,
several studies identified the miRNAs enrichments at synapse, synaptic vesicles and synaptosomes. However,
the role of synapse-associated miRNAs in AD progression is completely unexplored. In the first part of our
study, we identified synaptosome-specific miRNAs those were deregulated in AD and involved in nervous
system development, cell junction organization, synapse assembly formation, and function of GABAergic
synapse. The high expression of synaptosomal miRNAs were significantly correlated with Braak stage-based
disease progression. Currently we are studying the protective and/or deleterious properties of synaptosomal
miRNAs against Aβ and p-tau toxicities. The effects of synaptosomal miRNAs will be determined on overall
synapse functions and synaptic activity. In second part we will determine the role of synaptosomal miRNAs in
Aβ induced synaptic and cognitive dysfunction in AD. The impact of synaptosomal miRNAs will be studied on
healthy neurons and AD neurons with Aβ induced toxicities. We will focus on neuronal processing, neuronal
growth and network development and synaptic plasticity using APP primary neuronal cultures. Alteration of
synaptosomal miRNAs expression and synaptic proteins will be studied with disease progression in APP
transgenic (TG) and APP knockout (KO) mice. We will execute the synaptosome-specific miRNAs expression
with various cognitive behavioral and biochemical tests in 2-, 6-, 12- and 18-month-old APP TG and APP KO
mice lines relative to age-matched TG negative wild-type (WT) mice. Lastly, we will study the role of
synaptosomal miRNAs in phosphorylated-tau (p-tau) induced synaptic and cognitive dysfunction in AD. The
impact of synaptosomal miRNAs will be studied on p-tau induced toxicity in neurons, healthy neurons
processing, neuronal growth and network development and synaptic plasticity using tau primary neuronal
culture. Alteration of synaptosomal miRNAs and synaptic proteins will be studied with disease progression in
Tau TG and Tau KO mice. We will execute the synaptosome-specific miRNAs expression with various
cognitive behavioral and biochemical tests in 2-, 6-, 12- and 18-month-old tau TG and KO mice relative to WT
mice. Our study outcome will provide the answers for - 1) deregulation of synaptosomal miRNAs at AD
synapse, 2) synaptosome-associated miRNAs linked with Aβ and p-tau pathologies in AD, 3) Overall synapse
function, synaptic activity, assessment of therapeutic value of synaptosome-associated miRNAs in AD.

Public health relevance
Project narrative GABAergic neurons, the most common inhibitory neurons present in the human brain, were found to be dysfunction in Alzheimer’s disease. The molecular mechanism about the deregulation of GABAergic synapse function is largely unknown in Alzheimer’s disease. The present study is designed to understand the molecular mechanism behind the GABAergic synapse dysfunction in Alzheimer’s disease.